PROLONGED BALLON INFLATION ON RESTENOSIS FOLLOWING CORONARY ANGIOPLASTY

This study is to compare the patency of coronary arteries treated with prolonged balloon inflation vs. standard inflations during PTCA.